Optimization of Saturation Targets And Resuscitation Trial (OptiSTART)

PROJECT SUMMARY
This study is designed to answer one of the fundamental gaps in knowledge in the resuscitation of preterm
infants at birth: What is the optimal target oxygen saturation (SpO2) range that increases survival without long-
term morbidities? Oxygen (O2) is routinely used for the stabilization of preterm infants in the delivery room
(DR), but its use is linked with mortality and several morbidities including bronchopulmonary dysplasia (BPD).
To balance the need to give sufficient O2 to correct hypoxia and avoid excess O2, the neonatal resuscitation
program (NRP) recommends initiating preterm resuscitation with low (≤ 30%) inspired O2 concentration (FiO2)
and subsequent titration to achieve a specified target SpO2 range. These SpO2 targets are based on
approximated 50th percentile SpO2 (Sat50) observed in healthy term infants. However, the optimal SpO2
targets remain undefined in the preterm infants. Recent data suggest that the inability to achieve SpO2 of 80%
by five minutes is associated with intraventricular hemorrhage (IVH) and mortality. These studies raise concern
that current SpO2 targets (Sat50) may be too low resulting in persistence of high pulmonary vascular
resistance, respiratory failure and mortality. Preliminary data from my NICHD K23 funded pilot randomized
controlled trial (RCT) of 75 preterm infants <31 weeks gestational age (GA) showed that infants randomized to
75th percentile SpO2 goals (Sat75) had a lower incidence of SpO2 <80% at five minutes in the DR compared to
infants randomized to 50th percentile SpO2 goals (Sat50). In addition, Sat75 infants had less oxidative stress at
one hour after birth, needed less respiratory support on admission, had less pulmonary hypertension and had
higher survival without BPD. We hypothesize that delivery room resuscitation of preterm infants < 31 weeks
GA with Sat75 targets compared to Sat50 targets will increase survival without BPD by 36 weeks’
postmenstrual age (PMA). We plan to conduct a multicenter RCT of Sat75 versus Sat50 powered for survival
without BPD. We will randomize 772 infants, 230/7- 306/7 weeks’ GA, to Sat75 (intervention) or Sat50 (control).
Except for the SpO2 targets, all resuscitations will follow NRP guidelines including an initial FiO2 of 0.3. In Aim
1, we will determine whether targeting Sat75 compared to Sat50 increases survival without BPD. In addition,
we will compare the rates of other major morbidities such as IVH. In Aim 2, we will determine whether targeting
Sat75 compared to Sat50 increases survival without neurodevelopmental impairment at 2 years of age. In Aim
3, we will determine whether targeting Sat75 compared to Sat50 decreases oxidative stress. We will conduct a
sub-study of 220 infants enrolled from a single site to measure 8-iso-PGF2α and 8-OHdG in cord blood and
blood samples collected at 1 and 24 hours after birth. The new understanding gained from this trial has the
potential to modify neonatal resuscitation practice and improve neonatal outcomes worldwide. This will be the
first clinical trial powered for survival without BPD to evaluate competing DR SpO2 goals and addresses a
critical knowledge gap recognized by NRP and NICHD.

Public health relevance
PROJECT NARRATIVE This proposal will test if delivery room resuscitation of preterm infants < 31 weeks GA with 75th percentile SpO2 targets (Sat75) compared to 50th percentile SpO2 targets (Sat50) will result in better pulmonary transition, less oxidative stress and increased survival without bronchopulmonary dysplasia by 36 weeks’ postmenstrual age. If the research hypothesis is proven, it provides a simple and inexpensive way to reduce death or bronchopulmonary dysplasia in preterm infants worldwide. Further, it has potential to transform the delivery room management of preterm infants worldwide.